Development of a bioabsorbable, subcutaneous, extended-release buprenorphine implant for opioid use disorder

Project Summary/Abstract
The Drug Delivery Company (DDC) is developing a bio absorbable, extended-release buprenorphine implant. It is intended to
help address the challenges posed by opioid use disorder (OUD) and the fentanyl overdose crisis. Currently, the longest-lasting
formulation of buprenorphine (BUP) is a one-month long-acting injection (Sublocade ® and Brixadi ®). An extended-release
buprenorphine (XR-BUP) implant, capable of releasing therapeutic levels of BUP for over 6 months, will improve medication
compliance and provide a new treatment option for patients and healthcare providers.
In collaboration with the National Institute on Drug Abuse (NIDA), DDC has been actively involved in developing a
subcutaneous, bioabsorbable, extended-release 6-month naltrexone (NTX) implant since 2019. Building upon the success of
the 6-month bioabsorbable naltrexone implant, known as the iSTEP-N®, DDC is now creating a 6-month bioabsorbable
buprenorphine implant using the same technology.
The iSTEP-N® utilizes a patented bioabsorbable drug delivery platform, which is protected by U.S. Patent No. 11,197,819. In
pre-clinical studies, the iSTEP-N® implants demonstrated the release of therapeutic plasma levels of NTX for over 7 months
in canines with a mean plasma concentration of 5.3 ng/ml, with detectable levels persisting for more than 8 months. The
iSTEP-N® was well-tolerated, and no adverse events were reported. The FDA granted an Investigational New Drug (IND)
approval without clinical hold [IND 152127] for the iSTEP-N®, allowing the company to commence a phase I clinical trial in
healthy volunteers (Q2 of 2024).
The development plan for the XR-BUP implant (iSTEP-B) will be to follow the roadmap that was used for the iSTEP-N®
naltrexone implant. The chemical similarities between NTX and BUP allow for the loading of BUP into the iSTEP-N® drug
delivery platform. This study is targeting the same plasma concentration for both the NTX and BUP implants, which is > 2-4
ng/ml throughout the entire 6-month duration of the implant.
At this stage, there should only be minor adjustments made to the methodology used in developing the iSTEP-N® naltrexone
implant. The development process for the bio absorbable, extended-release buprenorphine implant will follow the same
pathway, including implant formulation, chemistry, manufacturing, and controls (CMC) analytics, non-GLP animal studies,
GLP IND-enabling toxicology studies in rodents and canines, submission of the IND application to the FDA, and ultimately
the completion of Phase I and Phase II Clinical trials.
The effectiveness of a 6-month buprenorphine implant is expected to provide stability and support for OUD patients during
those critical initial six months of recovery. Subsequently, with only two annual office visits required for a new XR-BUP
implant, patients can focus on psychosocial therapy, recovery, and rebuilding their lives. An XR-BUP implant, releasing
therapeutic buprenorphine for over 6 months, will enhance medication compliance and offers a fresh solution to opioid use
disorder and the fentanyl overdose crisis.

Public health relevance
Project Narrative The Drug Delivery Company (DDC) is developing a bio absorbable, extended-release buprenorphine (XR-BUP) implant. DDC has previously developed a subcutaneous, bio absorbable, extended-release 6-month naltrexone (NTX) implant and is now creating a 6-month bioabsorbable buprenorphine implant using the same drug delivery platform. An XR-BUP implant, releasing therapeutic buprenorphine for over 6 months, will enhance medication compliance and offer a fresh solution to opioid use disorder and the fentanyl overdose crisis.